Center for Environmental Genetics

OVERALL – Project Summary
The vision of the Center for Environmental Genetics (CEG) is to become a global leader in gene-environment
interaction (GXE) research and translation. Its mission is to conduct innovative, multidisciplinary GXE research
and translate discoveries to disease prevention via community empowerment, at home and around the globe.
The Center is a pioneer in GXE research. We have made outstanding progress in the current funding cycle with
new initiatives in advancing the understanding of epigenetics as a bridge between genetics and the environment;
further defining windows of susceptibility; identifying mechanisms underlying early-origins of complex diseases;
and discovering the impact of genetic variants on disease susceptibility. In the coming fund cycle, we will continue
on a steep trajectory of progress in mechanism-based GXE knowledge and translation to reduce environment
disease. Our optimistic outlook is based on the valuable intellectual and physical Center resources that we have
developed over the past 25 years. First, we have built ten highly valued cohorts, conducive to environmental
health sciences (EHS) research within the CEG or shared with other NIEHS-EHSC Centers. Second, we have
established leading-edge technologies and capabilities in high-throughput multi-omics research. Third, we have
some of the most advanced bioinformatics methods and modern pipelines in data analysis to unlock the power
of omics for better understanding of the mechanistic basis underlying complex diseases. Finally, we have
attracted incredible young talent ready to become the next-generation of EHS leaders through mentoring by a
cadre of thought-leaders in the field. Our strength is immense, our resources run deep, and our cohesiveness
supports a strong Center identity. Looking to our new funding cycle, we have the following future goals: (1) To
expand from regional to international cohorts to further our study of emerging environmental contaminants; (2)
To develop novel statistical and bioinformatics methods to identify the individual and cumulative effects of
exposures and the interactions of chemicals in a mixture; (3) To extend our omics platform to single-cell
transcriptome with epigenome analyses, interrogation of the mitochondrial genome and epigenome and
applications of metagenomics to microbiome; (4) To realize the potential of GXE research towards precision
medicine-based risk assessment, prevention, and therapies; (5) To minimize environmental disease and
promote healthier living in clean environments through partnerships with communities, health care professionals,
and policy-makers and to sharpen our focus on vulnerable populations with significant health disparities. Our
goals are well-aligned with the eleven goals of the NIEHS Strategic Plan. We believe we again will significantly
contribute to the EHS base of knowledge with new concepts and technologies, and develop human capital
through training. Our efforts will minimize the impact of environmental exposures on health in Greater Cincinnati,
in our nation and across the globe.

Public health relevance
Overall-Project Narrative The Center for Environmental Genetics is focused on minimizing the impact of environmental exposures on vulnerable individuals and populations through nurturing new generation of researchers, implementing new technologies, collaborating with multiple disciplines and enhancing bidirectional communications with community members, healthcare professionals and policymakers with new knowledge learned from gene- environment interactions and their ensuing human health effects.